A Multi-omics Investigation of Incident Persistent Tinnitus

ABSTRACT
Over 50 million Americans experience tinnitus. Persistent tinnitus can cause considerable suffering and
disability, impairing sleep, cognition, mental health and daily function, and the economic burden due to
disability, lost productivity and healthcare costs is substantial. However, little is known about the precipitants
and pathways that lead to persistent tinnitus and treatment options are limited. Our long-term goal is to identify
treatment targets and preventative strategies to reduce tinnitus burden and improve quality of life. Our overall
objectives are to (i) identify novel metabolomic and multi-omic risk factors for the development of tinnitus
among two large longitudinal cohorts of women (N>26,000); and (ii) collect tinnitus-related individual level data
in two additional ongoing cohorts of younger and more diverse men and women (N>70,000). Our central
hypotheses are that specific plasma metabolites are associated with risk of developing tinnitus and that genetic
variants influence how environmental exposures contribute to the development of tinnitus. The rationale is that
identifying risk factors for tinnitus will provide a strong scientific framework for improving tinnitus management,
and expanding data collection to include younger individuals will create a comprehensive resource that will
enable studies of genetic and environmental factors and will be invaluable in advancing future tinnitus
research. The study objectives will be addressed in three specific aims: 1) Identify plasma metabolomic risk
factors for developing persistent tinnitus; 2) Evaluate genomics and gene-environment interactions as risk
factors for developing persistent tinnitus; and 3) Collect tinnitus information in two ongoing cohorts of younger
individuals. We will leverage rich assets from four longitudinal cohort studies and findings from two large
tinnitus genome-wide association studies (GWAS). In Aim 1, we will use logistic regression to identify novel
metabolomic risk factors for developing tinnitus. In Aim 2a, we will conduct a GWAS and perform a meta-
analysis with published tinnitus GWAS results from the UK Biobank. In Aim 2b, we will assess how genetic
variations in enzymes responsible for caffeine and analgesic metabolism modulate associations between
caffeine intake or analgesic use and tinnitus risk. In Aim 3, we will leverage regularly administered
questionnaires in 2 well-characterized younger cohorts to collect detailed tinnitus information. This innovative
proposal integrates omics with epidemiological data to identify new risk factors for tinnitus, improve
understanding of tinnitus etiology and reveal metabolic pathways and candidate genes for future functional
follow-up. The proposed research is significant because identifying risk factors and omics precursors may
enable earlier neuroprotective interventions when treatments are more likely to be effective. As an early-stage
investigator, this project will provide me with necessary preliminary data for a future R01 proposal to extend
these large-scale multi-omics investigations of tinnitus, identify additional novel risk factors, and uncover new
treatment targets in women and men across the lifespan, and advance my career to the next stage.

Public health relevance
NARRATIVE The proposed project is relevant to public health as this research will contribute to fundamental knowledge about risk factors for developing tinnitus and the metabolic pathways and genetic influences that underlie its persistence. The long-term goal of this research is to identify treatment targets and preventative strategies to reduce the considerable public health burden due to tinnitus-related disability, lost productivity, and mental health suffering, and thereby improve quality of life. This research exemplifies the NIH mission to reduce illness and disability and will advance the mandate of the NIDCD to improve the lives of those with auditory disorders.